Microtubule Deficit in Glaucoma

Our objective is to identify new molecular targets for early detection and treatment of glaucoma. During the
progression of glaucoma, the axons of the retinal ganglion cells (RGCs) are gradually lost. Our hypothesis is that
axonal microtubules (MTs) are critically involved in the process. We demonstrated recently, using second-
harmonic generation (SHG) microscopy as a novel retinal imaging and DBA mice as a model of inherited
glaucoma, that axonal MTs degrade more rapidly than the loss of RGC axons (‘MT deficit’) and MT deficit is
spatially correlated with axonal atrophy. Our results suggest that MT deficit is a new pathology of early glaucoma,
which may have a common pathogenic origin as the loss of RGC axons. Here we aim to explore the capacities
of newly discovered pathology beyond early detection. We hypothesize that MT deficit may represent a reversible
stage suitable for therapeutic intervention and provide the molecular substrate for the RGC’s sensitivity to the
elevated IOP triggering the pathological response. To test this notion, the mechanism of MT deficit must be
elucidated. As a potential target, we will interrogate the posttranslational modifications (PTMs) of axonal MTs,
also known as the tubulin codes, which modulate the interaction between MTs and MT-associated proteins
(MAPs). Our research will show how MT PTMs are altered during glaucoma and whether the change is correlated
with MT deficit. Also, we will test MT deficit as an endpoint marker of the RGC viability evaluating the efficacy of
therapeutic treatments. We will analyze the DBA retina receiving an increased level of NAD+ to protect the RGC
axons. Our research can yield valuable insights into the mechanism of MT deficit and open a new line of
questions toward improved glaucoma therapy.

Public health relevance
Glaucoma is a leading cause of blindness worldwide, but currently there is no cure to reverse or prevent the progressive vision loss. Developing effective therapy is hampered by the lack of full understanding of the pathogenic mechanism. Here we will investigate the role of microtubule cytoskeletal element in the retinal nerve fibers. Based on our recent discovery that microtubules in the axons of the retinal ganglion cells are disrupted early in glaucoma, we hypothesize that the posttranslational modifications of the axonal microtubules, which is known to modulate the interaction with microtubule-associated proteins including molecular motors, might provide a molecular target for glaucoma. We will test this idea using a mouse model of glaucoma. Also, we will test whether metabolic rescue will recover the axonal microtubules, thus protecting the retinal nerve fibers.